Expanding the cancer paralog genetic interaction map to enable precision oncology

PROJECT SUMMARY/ABSTRACT
Recent advances in targeted therapies have prolonged the survival of non-small cell lung cancer patients.
However, lung cancer still remains the leading cause of cancer deaths in the U.S. and worldwide, and the 5-year
survival rate for non-small cell lung cancer is a dismal 24%. For many tumors, drug-targetable mutations are not
identified, limiting therapeutic options to chemotherapy or immune checkpoint inhibitors. For those that do have
identified druggable biomarkers, such as EGFR mutations, acquired resistance is near-universal problem. To
make progress in extending lung cancer patient survival, it is necessary to identify new targets beyond those
that are currently known.
Genome-wide CRISPR knockout screens are increasingly used to identify new cancer drug targets. However,
these assays still suffer from a major limitation, as single-gene knockouts generally do not reveal the functions
of gene families that have redundant functions, such as paralogs. Remarkably, it is now clear that paralogous
genes constitute two-thirds of the human genome, so this blind spot appears to be cover much of the genomic
landscape. To fully interrogate the function of all human genes, we are developing and deploying new methods
for multiplexed gene knockouts. In addition, the same duplications that make paralogs difficult to study could
also provide new, potentially customizable, approaches to cancer therapy, since the deranged genomes typical
of cancer cells commonly harbor deletions and inactivating mutations in one or more paralogs. We hypothesize
that targeting the actively expressed paralog in cancers that have lost or suppressed its paralogous pair could
create a synthetic lethal non-oncogene dependency and a therapeutic window for killing cancer cells.
Here, we propose to overcome the major barriers impeding the development and application of new synthetic
lethal therapies. First, we will build on the success of our paralog work since the first submission by performing
rapid and efficient systematic knockout of synthetic lethal paralogs across multiple cell types. Second, we will
apply our innovative paralog Perturb-seq approach to determine what paralogs undergo transcriptional
adaptation. Last, we will develop reproducible software to perform analysis of dual gRNA CRISPR screens,
enabling the broad adaption of our methods for genetic interaction mapping which may go beyond paralogs.
Ultimately, our findings will deliver new cancer targets that can be used to develop and deploy new therapies.
The impact of this project will be the identification of dozens to hundreds of new paralog genetic interactions
and demonstration that some of these can be harnessed to suppress tumor growth and drug resistance. Due to
the low anticipated off-target effects of synthetic lethal therapies, these could be applied in combination with
existing targeted-, immuno-, or chemo-therapies to suppress drug resistance and improve patient survival.

Public health relevance
PROJECT NARRATIVE Targeted therapies have improved lung cancer patient survival, but not all tumors harbor druggable targets and those that do invariably develop drug resistance. New drug targets are needed that could be used alone or in combination with existing therapies to improve patient survival. Here we will develop a new therapeutic approach based on a concept called “synthetic lethality” and validate this approach as a therapeutic strategy for suppressing cancer growth and drug resistance.